Multiomics analysis of the microbiome and subclinical cardiovascular disease in HIV infection

PROJECT SUMMARY
This K01 Career Development Award application proposes a multidisciplinary 5-year training program to
provide the candidate, Dr. Zheng Wang, with the experience and resources necessary to launch a successful
career as an independent investigator. The training plan, developed closely with primary mentor Dr. Qibin Qi,
co-mentors Drs. Robert Burk and Jorge Kizer, and an Advisory Committee (Drs. Rob Knight, Robert Kaplan,
Tao Wang, and Anjali Sharma), will expand Dr. Wang’s research experience and expertise, in oral microbiome,
integrative multi-omics analyses, and cardiovascular disease (CVD) epidemiology. Building upon two well-
characterized HIV cohorts (Women's Interagency HIV Study, WIHS; Multicenter AIDS Cohort Study, MACS)
and pre-existing circulating metabolomics and proteomics data, the proposed research project offers the
candidate an exceptional opportunity to become proficient in the novel area of oral microbiome and integrative
multi-omics analyses research, in the field of CVD epidemiology in HIV population. Taking advantage of
collected oral saliva samples, carotid atherosclerosis (measured by ultrasound) and cardiac fibro-inflammation
(measured by magnetic resonance imaging) data, circulating metabolomics data and proteomic inflammatory
markers data in the WIHS, this project proposes to measure oral microbiome taxa and functional components
using shotgun metagenome sequencing, in 320 participants (216 HIV+ and 104 HIV-; 84 with carotid artery
plaque and 236 without plaque). We will identify alterations in the oral microbiome associated with HIV-related
factors, and examine associations of oral microbiome features with subclinical carotid atherosclerosis and
cardiac fibro-inflammation. We will further investigate the oral-gut microbiome crosstalk (with pre-existing gut
metagenomics data) and its implications in subclinical CVD, in the context of HIV. Replication analysis will be
performed in 400 MACS participants to validate the findings. Moreover, we will examine prospective
associations of baseline microbial-associated metabolites with incident carotid artery plaque over 7-years
follow-up (n=737), to explore the role of microbiota in CVD development. Employing advanced "multi-omics"
analytical approaches, we will examine the microbiome–metabolome–proteome interactions and generate a
network illustrating interrelationships between oral and gut bacteria, circulating metabolites, proteomic
inflammatory markers, microbial translocation biomarkers, CVD and HIV infection.
Findings from this study will provide preliminary data for a larger study proposal to measure oral and gut
microbiome longitudinally and integrate microbiome with other omics data more comprehensively. These
studies will advance our understanding of interrelationships among microbiome, host inflammation and
metabolism, and shed light on potential underlying mechanisms, which will provide useful information for
effective strategies in the prevention and management of CVD in people living with HIV.

Public health relevance
PROJECT NARRATIVE As people living with HIV experience longer lifespans (even reaching normal life expectancy) due to highly active antiretroviral therapy, cardiovascular disease (CVD) has emerged as a leading cause of morbidity and mortality. The proposed research project aims to identify potential microbial features, biomarkers, and targets for individual CVD risk prediction and prevention. This holds promise for personalizing medication, such as therapeutic modulation of the microbiome and other interventions, to avert CVD among HIV-infected patients.